Therapeutic targeting of an oncogenic translational program in AML

PROJECT SUMMARY
CBFβ-SMMHC is the driver oncogene in acute myeloid leukemia (AML) with the chromosome inversion
inv(16)(p13q22). CBFβ-SMMHC induces AML by sequestering RUNX1, the transcription factor that plays an
important role in normal hematopoiesis. Adult inv(16) AML patients present poor clinical outcomes - 30-40% of
these patients relapse and die from the disease. This suggests developing better therapeutic strategies for
treating inv(16) AML is critical. We recently developed a small molecule inhibitor, AI-10-49, which specifically
disrupts CBFβ-SMMHC binding to RUNX1. AI-10-49 treatment induced leukemic cell apoptosis in human primary
inv(16) AML cells and enhanced survival in an inv(16) mouse model. AI-10-49 is the first targeted therapy for
inv(16) AML and is under development as an anti-leukemic drug. In a recent study, we explored the mechanism
of action of AI-10-49. We found that AI-10-49-induced cell death is partly mediated by inhibition of the eukaryotic
translation initiation factor 4 gamma 1 (eIF4G1) in inv(16) AML cells. eIF4G1 inhibition leads to apoptosis in
inv(16) AML cells, indicating eIF4G1 as a therapeutic target. We also found that reactivation of eIF4G1 is a major
source of AI-10-49 resistance in inv(16) AML cells, and eIF4G1 inhibition by the small molecule inhibitor SBI-
756 can overcome drug resistance in inv(16) AML cells. Our results provide proof-of-concept for testing eIF4G1
inhibitors in combination with AI-10-49 to overcome drug resistance during treatment of inv(16) AML. Our data
suggest that overexpression of eIF4G1 by CBFβ-SMMHC is a critical step in inv(16) AML transformation. We
hypothesize that CBFβ-SMMHC activates eIF4G1 in inv(16) AML, altering protein synthesis and rewiring the
AML proteome, which, in turn, promotes leukemogenesis and reactivation of eIF4G1, contributing to AI-10-49
resistance. We will test this hypothesis by i) characterizing the therapeutic value of SBI-756, an eIF4G1 small
molecule inhibitor, in inv(16) AML cell survival using a CBFβ-SMMHC genetic mouse model and an inv(16) AML
patient-derived xenograft model, and ii) defining the mechanisms of action of eIF4G1 in inv(16) AML.

Public health relevance
PROJECT NARRATIVE The proposed research is of high conceptual and clinical significance because it lays the foundation for a better understanding of how oncogenes rewire the proteome and selectively regulate the translation of mRNAs essential for survival in multiple types of cancer. The health-relatedness of this knowledge is that the proposed research may provide proof-of-concept for testing eIF4G1 inhibitors in combination with AI-10-49, and other small molecule inhibitors for treating cancer.